Role of inflammation in TET2 mediated clonal hematopoiesis in the context of bone marrow niche

Clonal hematopoiesis (CH) occurs due to the accumulation of somatic mutations in hematopoietic stem and
progenitor cells (HSPCs). The presence of CH increases the risk for the development of hematological
malignancies by 12-fold and heart disease by more than 2-fold. TET2, a gene involved in regulation of cytosine
methylation, is one of the most frequently mutated drivers of CH. Mounting evidence and our preliminary data
shows that expansion of HSPCs with Tet2 loss-of-function (Tet2-KO) is strongly promoted by inflammation.
Unfortunately, the underlying mechanisms driving expansion of Tet2-KO HSPCs, as well as the relative
contribution of the niche, is not defined. My long-term goal is to understand which targetable pathways are
regulated by inflammatory stress to promote CH. Identified factors could serve as early intervention and disease
monitoring strategies. We have found in vivo that interleukin 1 beta (IL1β) promotes preleukemic
myeloproliferation and expansion of Tet2-KO HSPCs over healthy cells. Furthermore, in vitro assessment shows
that self-renewal ability of Tet2-KO HSPCs is significantly increased upon IL1β exposure. Interestingly, IL1β-
mediated myeloid expansion of Tet2-KO HSPCs is also supported by non-hematopoietic bone marrow niche
cells. Further IL1β alters the composition of the bone marrow stromal niche when Tet2-KO hematopoietic cells
are present. To identify transcriptional changes impacting self-renewal and myeloid expansion of Tet2-KO
HSPCs, single cell RNA sequencing of bone marrow derived Tet2-KO and healthy HSPCs treated with or without
IL1β was performed. These data revealed upregulation of pathways and genes related to self-renewal, cytokine
signaling, and myeloid differentiation in the IL1β treated Tet2-KO HSPCs relative to healthy HSPCs.
Cumulatively these data led me to my overarching hypothesis that IL1β drives expansion of Tet2-KO HSPCs
through the alteration of transcriptional and epigenetic signaling while impacting niche interactions with
HSPCs. I will address my hypothesis by following two aims. Aim 1 will identify the mechanism driving expansion
of Tet2-KO HSPCs in the context of IL1β induced chronic inflammation. I will utilize genetic and pharmacological
inhibition approaches to identify the role of candidate genes impacting fitness of Tet2-KO HSPCs relative to
healthy cells. Further, I will use rapid immunoprecipitation mass spectrometry of endogenous proteins (RIME)
and chromatin immunoprecipitation (ChIP-seq) to identify how IL1β and TET2 alter methylation to promote
expansion of Tet2-KO HSPCs. In Aim 2, I will determine how reprogramming of the bone marrow niche by IL1β
impacts fitness of Tet2-KO HSPCs relative to healthy cells. Specifically, I will use cytometry by time of flight
(CyTOF) and differentiation assays to characterize how IL1β alters the stromal component of the bone marrow
niche. Finally, I will examine how niche cells in response to IL1β impacts Tet2-KO HSPCs expansion using in
vitro coculture assays. Cumulatively, these studies will define the inflammation-mediated mechanisms driving
TET2 CH, providing targets for early intervention and detection by reducing the fitness of TET2 HSPCs.

Public health relevance
PROJECT NARRATIVE Exposure to inflammation can promote fitness of mutated blood stem cells and reduce the fitness of healthy cells, a process known as clonal hematopoiesis (CH). My proposed study will identify the mechanisms by which inflammatory stress provides advantage to these mutated CH cells and reprograms their supportive niche. This knowledge will be harnessed to inform strategies that can mitigate CH progression to leukemia or cardiovascular disease.